In crystallo biomimetic oxygenase chemistry within peptidic frameworks

Mononuclear non-heme Fe and Cu sites in oxygenases functionalize the highly inert C–H bonds of substrates involved in metabolism, natural product synthesis, and biogeochemical cycles, all of which directly impact human health. Despite the importance of these enzymes, the structures and properties of many key enzymatic intermediates are not fully understood. Synthetic analogs of the intermediates facilitate more in-depth studies, but current models have shown that the protein environment, or lack thereof, significantly affects reactivity. Site-isolation, weak-field ligands, and noncovalent secondary interactions are hallmarks of oxygenase active sites, but these features are difficult to simultaneously replicate in synthetic systems. To address these gaps, our laboratory has developed single-crystalline peptide assemblies (or “frameworks”) that bind metals in their porous channels using amino acid residues. Our central hypothesis is that usage of peptide-based coordinating groups allows direct comparisons between the model system and the enzyme, while the crystalline matrix stabilizes reactive species for structure determination by X-ray crystallography. We have reproduced the critical facial triad coordination (2His/1-carboxylate) for non-heme Fe sites, from which we will explore the structures and chemistry of the fleeting high-valent intermediates relevant to the enzyme mechanism. The Cu versions of these frameworks are also appropriate models for the active site of particulate methane monooxygenase (pMMO), whose active site has been long-debated and recently postulated to be a single Cu site bound to a 2His/Asp ligand set. Given the modularity and ease of peptide synthesis, we will tune the structures of these sites to obtain detailed structure-function correlations that will illuminate how protein environments elicit remarkable inorganic reactivity. The outcomes of this research are expected to fill in key gaps in the mechanism of these enzymes and inform the design of mechanism-based therapeutics, as well as catalysts for pharmaceutical synthesis, and water remediation.

Public health relevance
The insertion of oxygen atoms into molecules by non-heme oxygenase enzymes is involved in numerous biological processes, and therefore greatly impacts human health. These diverse enzymes share a common active site but it is unclear how they achieve such a wide range of functions. A better understanding of the active site structure-function relationship, which we will achieve using accurate model systems, is expected to illuminate fundamental chemistry that will help explain the importance and versatility of the non-heme oxygenase active sites. Thus, the research aligns with mission of NIGMS to better understand the fundamental biological processes of living organisms.